RBC transfusion exacerbates brain inflammation in anemic murine neonates and causes long term neurodevelopment impairment

Project Summary
Red Blood Cell Transfusions (RBCT) are necessary and life-saving in premature and critically ill infants, who
experience severe anemia due to both physiologic and iatrogenic factors. Recently, we have elucidated the
connection between anemia and necrotizing enterocolitis (NEC); specifically, the “leaky gut” presentation
characterized by monocytic infiltration, RBC transfusion-associated activation of infiltrated monocytes, and the
resulting intestinal mucosal injury. Neurocognitive development is often impaired in patients with NEC and, a
large clinical trial confirmed that RBC transfusion in extremely premature infants may contribute to these
neurodevelopmental outcomes. This finding is supported by several preclinical studies. However, the underlying
mechanism(s) by which anemia and RBC transfusion directly or indirectly correlate with neurocognitive
impairment through the development of an inflammatory cascade is unclear. Critical evaluation of the association
between anemia/RBC transfusion and anemia-transfusion-associated brain inflammation (ATBI) and their effects
on neurodevelopment are necessary to improve clinical practice and develop therapeutic strategies for
prevention or amelioration. Our preliminary studies using our established pre-clinical murine model of
anemia/RBC transfusion demonstrate that anemia is associated with a “leaky gut” that leads to endotoxin in the
bloodstream, causing early brain inflammation by activation of microglia. Then, RBC transfusion potentiates this
early brain inflammation by recruitment of NEC-causing monocytes (raised from the intestine) in the brain.
Consistent with this finding, the brain inflammatory response could be dampened either by depletion or inhibition
of NEC-causing monocytes. Thus, here we will propose a novel hypothesis that anemic neonates are uniquely
predisposed to early brain inflammation, and RBCT exacerbates this brain inflammation leading to altered
neurodevelopment. We propose this finding in anemic premature infants due to infiltration of inflammatory
activated monocytes, with a phenotype similar to monocytes found in the anemic-RBC transfused intestine via
the ‘gut-brain axis’. To test our central hypothesis, we will pursue the following specific aims: Aim 1: Elucidate
the mechanisms by which severe anemia and RBCT induce/exacerbate monocyte infiltration and cause
inflammation in the neonatal brain. Aim 2: Investigate the role of RBCT-NEC causing monocytes in ATBI. Aim 3:
Determine the effect of phlebotomy-induced anemia and neonatal ATBI on neurocognitive impairment in
adulthood. Our studies will have therapeutic implications for treating anemia/RBC transfusion-associated brain
inflammation, as the elimination of the NEC-causing inflammatory monocytes could contribute to the amelioration
of neurodevelopment deficits.

Public health relevance
Project Narrative Preterm neonates comprise one of the most heavily transfused populations, as 50-94% of very low birth weight (VLBW) infants receive at least one RBC transfusion during their stay in the neonatal intensive care unit (NICU) to correct anemia, which is associated with increased morbidity and mortality worldwide. Though repletion with packed RBC transfusion has obvious benefits, transfusion in the setting of severe anemia has also been implicated in the subsequent development of necrotizing enterocolitis (NEC) and impaired neurocognitive outcomes. In this application, the investigator proposes sequential studies to investigate the role of anemia and/or RBC transfusion in anemic-transfused brain inflammation (ATBI), the mechanism(s) of NEC-causing monocytes in ATBI, and potential strategies to prevent their inflammation in the progression to ATBI.